A CT-Based Multiparametric Imaging Biomarker for Assessment of Pediatric Interstitial Lung Disease

PROJECT SUMMARY
Childhood (diffuse) interstitial lung diseases affects infants, children, and teens and
manifests as dyspnea, hypoxemia, and respiratory compromise resulting in high
morbidity and mortality or life-long sequelae for survivors. Despite improvements in the
understanding of and interventions for pediatric diffuse lung disease in the past 15
years, the current standard-of-care for confirmation and characterization of chILD by
thin-section chest computed tomography (CT) has had limited progress through visual
assessments that are inherently subjective and suffer from inter-reader variability in
defining the specific characteristic findings. This can limit accurate diagnosis of early
and progressive disease and translates to a more time-consuming and burdensome
clinical evaluation. An automated and objective approach to quantify common
radiological lung CT patterns observed in ILDs specifically in pediatrics would provide
more reliable information and reduce costs by standardizing and streamlining image-
based assessment.
In this grant proposal, Imbio Inc., an industry leader in developing, commercializing, and
achieving regulatory approval of imaging biomarker software, proposes to develop a
fully-automated software application for quantifying lung CT textures. The collaboration
leverages the clinical and research expertise at the Children’s Hospital Los Angeles
(CHLA) which is a large, safety-net pediatric hospital. The specific aims are 1) to
develop a data repository of chest CT scans in subjects with pediatric diffuse lung
disease and control subjects along with expert annotations of radiologic textures and 2)
develop and validate an integrated pediatric/adult deep-learning-based algorithm to
quantify radiological lung textures (i.e., DeepLTA). Upon completion of the aims, the
final algorithm will have broad applicability and generalizability to detect parenchymal
CT textures in both adult and pediatric ILDs. This will enable a Phase II submission and
integration of this software to enhance pediatric access to state-of-the-art quantitative
medical imaging analysis for improved prognosis, diagnosis, and therapy response
assessment in pediatric interstitial lung disease.

Public health relevance
PROJECT NARRATIVE Childhood (diffuse) interstitial lung disease comprises a group of parenchymal lung disorders associated with high morbidity and mortality and life-long sequelae for survivors. Development of imaging technology targeted towards automating identification of common radiological lung CT patterns in pediatric populations with interstitial lung disease is critical to improve early detection, accurately assess disease severity, and stratify patients based on therapeutic response thereby improving clinical outcomes in these patients. This project coalesces a unique pediatric diffuse lung disease chest CT imaging data repository and validates a deep-learning-based Lung Texture Analysis (DeepLTA) software to automate quantitative analysis for improved prognosis and diagnosis in childhood diffuse lung disease.